Understanding A Molecular Cascade That Drives Neutrophil Mediated Pathology In Arthritis

UNDERSTANDING A MOLECULAR CASCADE THAT DRIVES NEUTROPHIL MEDIATED PATHOLOGY IN ARTHRITIS
Rheumatoid arthritis (RA) is a frequent chronic disease of the synovial joints characterized by painful loss
of mobility due to unrestrained inflammation and progressive bone erosion. Disease etiology is poorly
characterized, and the available therapeutic approaches fail to control disease symptoms in many RA patients,
highlighting the critical need for identification of new therapeutic targets. A key event in RA is the influx of
leukocytes, such as neutrophils, into the joints, where they initiate and sustain inflammation and contribute to
bone erosion from the early stages of RA. While healthy synovial fluid is acellular, the most abundant cell type
found in the inflamed synovial fluid is the activated neutrophil.
Engulfment and cell motility protein-1 (ELMO1) is a regulator of actin cytoskeleton dynamics during
phagocytosis of dying cells and migration of lymphocytes. We demonstrated that Elmo1–/– mice develop
significantly milder disease in two models of inflammatory arthritis that share many features with human RA, and
that deletion of Elmo1 during established disease could improve arthritis symptoms and disease resolution. We
found that disease resistance is due to specific ELMO1 function in neutrophils, and that loss of ELMO1
significantly attenuated neutrophil activation and migration (induced by chemokines involved in arthritis) and
reduced neutrophil mobilization to the joints. Circulating Elmo1–/– neutrophils had reduced cell surface levels of
the tethering molecule CD62L, and reduced chemokine-induced exposure of the adhesion/migration-promoting
integrin CD11b. These data suggest that ELMO1 function may be required for multiple steps of the neutrophil
recruitment cascade to enhance neutrophil recruitment into joints. Surprisingly, loss of ELMO1 did not impair
neutrophil recruitment and function elicited by bacterial stimuli, indicating that therapeutic targeting of ELMO1
could maintain normal pathogen clearance. Finally, the RA-associated SNP rs11984075, located in an intron of
the ELMO1 gene, correlates with increased ELMO1 protein and elevated CD62L in neutrophils, suggesting that
RA patients with SNP rs11984075 could benefit from therapeutic approaches targeting ELMO1. We hypothesize
that ELMO1 contributes to tissue/stimulus-specific neutrophil recruitment and pathology in inflammatory arthritis.
In this proposal, we will address three specific aims: 1. Test if ELMO1 is required for stimulus- or tissue-
specific neutrophil recruitment. 2. Test if ELMO1 promotes neutrophil adhesion through CD62L/L-selectin, and
3. Identify the mechanism by which ELMO1 SNP rs11984075 elevates protein levels and test an inhibitor of
ELMO1 in arthritis. This proposal is significant because it will further our understanding of the role of ELMO1 in
neutrophil-mediated pathology in rheumatoid arthritis and could lead to the discovery of new diagnostic tools and
therapeutic strategies. Our proposal is innovative because it will advance new concepts in ELMO1 biology and
will generate new tools for the scientific community and for studying neutrophil functions.

Public health relevance
Rheumatoid arthritis (RA) is a common joint disease characterized by loss of mobility and chronic pain, in which currently available therapies remain without effect in 30-70% of the patients, suggesting a critical need for identification of new therapeutic avenues. We discovered that the engulfment and cell motility protein-1 (ELMO1) contributes to disease development in mouse models of RA by facilitating recruitment of immune cells called neutrophils into the joints, where they contribute to inflammation and bone degradation. In this proposal, we will delineate the mechanisms by which ELMO1 regulates neutrophil recruitment into joints, which could lead to the discovery of new targets for therapeutic development in rheumatoid arthritis.